Bioinformatics Core

Alaska INBRE 4 - BIOINFORMATICS CORE PROJECT SUMMARY
One Health recognizes that human health is connected to the health of animals and their shared environment.
These relationships in modern biomedical research enable researchers to study people, animals, plants, and
microbes and their interactions through multiple bottom-up “omics” methods. The results include massive
amounts of information about genes, proteins, and metabolites in an experimental system, which represents a
revolutionary technological advancement in biomedical research that also necessitates new tools to sort and
analyze the information. The AK INBRE 3 Bioinformatics Core established a distributed core model where
Alaska-based bioinformatics resources were augmented by support for access to external resources and
training from outside the University of Alaska network. The overall goals of the AK INBRE 4 Bioinformatics
Core are to provide state-of-the art services and training in bioinformatics and biostatistics for investigators and
students. The core will build on the successful AK INBRE 3 Core by providing enhanced support for Alaska
infrastructure, including massively-parallel “next-gen” sequencing and high performance computing, as well as
by promoting development of emerging bioinformatics technologies in the Alaska user group. Core activities
will leverage bioinformatics resources within the UA system and provide funding and guidance to investigators
to capitalize on external bioinformatics resources to build biomedical research capacity in Alaska. The Core
deploys a distributed model that leverages Alaska-based resources in high-performance computing, next-gen
sequencing, and biostatistics with funding support for AK INBRE scientists to use external resources and
training. With an overall goal to provide state-of-the art services and training for bioinformatics and biostatistics
for the AK INBRE community, the core will execute the following specific aims: 1) Provide access to
bioinformatics technology and data acquisition through the support of local equipment and expertise as well as
access to resources outside of Alaska; 2) Support bioinformatics and biostatistics experimental design and
data analysis through access to specialized Alaska-based and external expertise; 3) Support career
development and bioinformatics training for students, postdoctoral fellows, faculty and senior researchers in
the AK INBRE network through Alaska-based workshops and curriculum development, as well as through
support for external training; 4) Promote the development of emerging bioinformatics technologies that
enhance INBRE One Health research.